Metabolomics Core

PROJECT SUMMARY (See instructions): The goal of the Metabolomics Core (Core D) is to provide a central resource that will facilitate high throughput characterization of the metabolome in influenza virus infected cells and tissues. We will validate relevant metabolites and localize metabolites within infected tissues samples. The core will also design strategies to uncover host metabolic pathways that are impacted by, and that influence influenza virus infection and disease pathogenesis.

Public health relevance
RELEVANCE (See instructions): An better understanding of influenza infecfion and pathogenesis requires state-of-the-art tools for measuring the metabolism of infected cells. This Core will perform analysis of small metabolites associated with virus infecfion. These studies will help to define the fundamental ways that influenza causes disease